CORE--DNA AND CELL BANK

The DNA and Cell Bank core will prepare, store, and distribute cells, DNA, and synthetic oligonucleotides to the program project investigators. The Core will also coordinate access to a central data bank with clinical and laboratory data shared between each project investigator on the VMRC immunology program computer network. Detritylated oligonucleotides (12-15/mo) will be synthesized for use as primers and probes for projects 1-4. Genomic DNA will be prepared from PBL and LCL for use in the studies in projects 3 and 4. The Cell Bank will maintain LCL and monoclonal antibody hybridoma cell lines for use by all four projects and will maintain frozen stocks of PBL or T-cell lines and clones for use in projects 1 and 2.